Provider Support and Patient Outreach in Lung Cancer Screening

We propose to conduct a multi-level intervention randomized trial in four health systems (Christiana Care
Health System (CCHS), Jefferson Health (JH), Lehigh Valley Health Network (LVHN), and PennState Health
(PSH)) to test the combined and separate effects of a provider support intervention and a patient outreach
intervention on SDM and LCS in primary care practice. Using a mixed methods 2x2 factorial design, we initially
will recruit and randomize 28 primary care practices and providers either to a Provider Support Group (N=14)
or a Control Group (N=14). Over three years, we will also identify approximately 4,480 patients who are
potentially eligible for LCS and have a scheduled primary care visit. On a weekly basis, we will allocate
identified patients to cohorts and initiate telephone contact with each cohort to verify screening eligibility, obtain
consent, and complete a baseline survey. We will randomize at least 672 patient participants either to a
Patient Outreach Group (N=336) or a Control Group (N=336). Thus, the trial will involve a Provider
Support + Patient Outreach Group, a Provider Support Group, a Patient Outreach Group, and a Control
Group. We will collect health system electronic medical records (EMRs) data, study administrative data,
physician and patient survey data, and interview data from physicians, practice staff, health system care
coordinators, and health system leaders for use in addressing trial aims. Specific aims of the trial are as
follows: Aim 1. Assess intervention impact on Lung Cancer Screening (LCS); Aim 2. Assess intervention
impact on Shared Decision Making (SDM); Aim 3. Identify mediators and moderators of screening; and, Aim
4. Assess intervention implementation. We will use health system EMR data, study administrative data,
provider baseline and endpoint survey data, and patient baseline and endpoint survey data, focus group data,
and health system leader interview data to identify practice-, provider- and patient-level factors that impact
intervention effects on screening. In terms of overall impact, this trial will identify effective strategies for
increasing SDM and LCS rates in primary care and for implementing effective strategies in health systems. We
will disseminate study findings through communication channels in participating health systems and more
broadly by reporting results on ClinicalTrials.gov, at health care professional organization meetings, through
local, state and regional conferences, and via publications in peer-reviewed journals.

Public health relevance
Using a mixed methods 2X2 factorial design, we will conduct a multi-level intervention randomized trial in four health systems to test the combined and separate effects of primary care provider support and patient outreach on shared decision making and lung cancer screening.